Core 1: Bioethics Shared Resource

PROJECT SUMMARY – BIOETHICS SHARED RESOURCE (BESR)
(The Bioethics Shared Resource is identical for all three Partnering Institutions)
The Bioethics Shared Resource (BESR) is coordinated through the Tuskegee University (TU) Center for
Biomedical Research and includes bioethicists consulting for Morehouse School of Medicine (MSM), and the
University of Alabama O’Neal Comprehensive Cancer Center at Birmingham (UAB OCCC). The BESR
provides exceptional bioethics education, training, guidance, and consultation throughout the MSM/TU/UAB-
OCCC Partnership and spearheads research on bioethical issues. BESR activities fall under three overarching
and complementary objectives: (1) achieving competencies in content areas of bioethics with a focus on
cancer research ethics; (2) integrating bioethics concepts nationally, by presentation of a conference on
bioethical issues in cancer research, and throughout the Partnership by dialogue with researchers, clinicians,
faculty, students, patient advocates, community health advisors, patient navigators, recruiters, and key
personnel; and (3) conducting research to uncover and expand ethical issues from the perspectives of
underserved racial/ethnic minorities and making recommendations that inform scientific and behavioral
research and policy. The specific aims of the BESR are: (1) To expand on the strategic integration of bioethics
in all Partnership projects, at every stage of research, through collaboration with the Research Education and
Outreach Cores; (2) To collaborate in teaching graduate/undergraduate courses in bioethics, health disparities
and health policy, and bioethics in biosciences, and facilitating discussions of ethical issues in clinical trials
through the utilization of the bioethics experts across the three partner institutions; (3) To endow community
stakeholders, patient advocates, students, and investigators across all Cores and Projects with tools needed to
design, conduct, and manage ethical and culturally sensitive clinical studies through the implementation of an
e-Course on Good Clinical Practice (GCP) in social and behavioral cancer research; (4) To facilitate the ethical
engagement of study participants in medically underserved urban and rural areas of Alabama and Georgia,
addressing issues of trust/mistrust and the informed consent process in clinical and genomic studies; and (5)
To leverage the expertise and bioethics facilities at TU, MSM, and the UAB OCCC to conduct projects that
address bioethical issues in biomedical, social, and behavioral cancer research involving racial and ethnic
minorities. Expansion of these advances to the national level will be via presentation of a conference on ethical
issues in cancer research. Appropriate methods for achieving the stated aims are described in the Research
Strategy section. Planning and evaluation of outcomes are detailed in the Logic Model.